Multimorbidity among HIV-Infected Adults in North America from 2000-2010

DESCRIPTION (provided by applicant): Antiretroviral therapy has extended the life expectancy of persons living with HIV (PLWH) and, as a result, age-related comorbidities are increasingly commonplace. This observation will impact the clinical outlook of HIV care and management in older adults. Multimorbidity, the occurrence of ≥2 age-related comorbidities within the same individual, will invariably add to the already complex care needs of PLWH. However, there is limited research evaluating multimorbidity in the setting of HIV. Advancing current understanding is needed to formalize consideration of multimorbidity in HIV care guideline development, and respond to the National HIV/AIDS Strategy's call to improve long-term health outcomes in PLWH. Accordingly, this research aims to evaluate the epidemiology of multimorbidity and its influence on clinical care patterns among HIV-infected adults in the United States (US) and Canada from 2000-2010, with a particular interest in those with a history of injection drug use (IDU). Multimorbidity will be comprised of the following age-related comorbidities: hypertension, anemia, dyslipidemia, diabetes, renal impairment, myocardial infarction (MI), end-stage renal disease (ESRD), end-stage liver disease (ESLD), and non-AIDS malignancies. The proposed research will be nested within the North American AIDS Cohort Collaboration on Research and Design (NA-ACCORD), the largest cohort collaboration of HIV-infected adults in the U.S. and Canada. This population is well suited to address study objectives given its size, geographic heterogeneity, and demographic similarity to the broader population of PLWH in the US. Aim 1 will quantify the prevalence, incidence, and time between successive comorbidities, comparing multimorbidity in HIV-infected to-uninfected individuals. This aim will employ causal inference, competing risks, and multivariate survival analysis methods. Aim 2 will identify individual and regional-level factors that are associated with multimorbidity among HIV-infected individuals. This will be accomplished by multivariate survival analysis to address the correlated nature of comorbidities within individuals. Aim 3 will evaluate how multimorbidity impacts retention in care, adjusting for time-varying confounders, through causal inference modeling. For each aim, analyses will be stratified by individuals with a history of IDU and/or positive hepatitis C antibody. This population is of particular interest due to the excess burden of comorbidities that complicates their HIV care and treatment. This subgroup may especially benefit from targeted approaches to prevent multimorbidity and delay end-stage organ damage.

Public health relevance
PUBLIC HEALTH RELEVANCE: HIV-infected individuals are living longer as a result of successful therapy, making them eligible for age-related illnesses typically seen in older HIV-uninfected individuals. The accumulation of these age-related comorbidities within an individual, also known as multimorbidity, poses a great public health concern in light of an absence of guidelines to direct its management, as well as a limited understanding of what drives its development in HIV-infected individuals and in persons with a history of substance abuse. The foreseeable growth in multimorbidity burden, goal of the National HIV/AIDS Strategy to improve health outcomes among aging HIV-infected adults, and enactment of the Affordable Care Act, requires a critical understanding of how multimorbidity can be mitigated, and therefore examination of the following questions: 1) is the burden, rate, and progression of multimorbidity greater in HIV-infected compared with -uninfected adults; 2) what individual and regional-level factors influence the rate at which multimorbidity develops in HIV-infected adults; and 3) does multimorbidity impact being retained in HIV clinical care?